Mechanisms of rDNA instability during aging

Project Summary.
Genomic instability is one of the major hallmarks of aging conserved across all species. The repetitive
ribosomal DNA (rDNA) locus is one of the most vulnerable genetic loci to various types of DNA damage,
especially DNA double strand breaks (DSBs). The high level or rRNA transcription by RNA Polymerase I
can conflict with the DNA replication forks to cause significant DNA replication stress. To prevent
collisions, replication fork barriers (RFB) are typically established at the 3’ end of each active rDNA
transcription unit. The classic eukaryotic example is the Fob1 protein in budding yeast Saccharomyces
cerevisiae. Sloppy repair of Fob1-dependent RFBs trigger DSBs that can alter the rDNA copy number
and produce extrachromosomal rDNA circles (ERCs) that are proposed to cause replicative aging. Fob1
has long been thought to function exclusively at the rDNA. However, we have recently identified several
novel binding sites that also regulate rDNA stability and lifespan. Among these is the SIR2 gene, a major
promoter of longevity through stabilization of the rDNA array. Our preliminary results implicate Fob1 in a
regulatory network that functions with the Pol I transcription factor UAF to maintain rDNA copy number
homeostasis through control of rDNA recombination via DSBs. This proposal further investigates the
function of UAF and Fob1 in regulating DSBs and aging in yeast through an innovative whole genome
DSB mapping technology that we will also apply to human IMR-90 cells to determine how the functionally
analogous protein, transcription termination factor-1 (TTF1) controls RFB activity and DSB distribution in
a replicative aging/senescence cell line model. To complement the functional investigation of Fob1 and
TTF1, we will also determine the impact of aging on the 3D structure of Fob1 target sites via its role in
recruiting the condensin complex. We anticipate the project will establish novel roles for Fob1 in
regulating rDNA stability and aging in yeast and implicate TTF1 as a new regulator of rDNA stability in
human cells.

Public health relevance
Narrative. Repetitive DNA sequences in eukaryotic genomes such as telomeres, centromeres, and the ribosomal DNA (rDNA) are organized as tandem arrays that are difficult to replicate and prone to DNA damage, often in the form of DNA breaks. Aberrant repair of these breaks can result in instability of the arrays and severe changes in repeat copy number. In the case of rDNA, such instability and copy number changes are thought to be caused by a DNA replication fork barrier (RFB) established by the Fob1 protein that also regulates aging. Similar RFBs occur at the rDNA in mammalian cells, yet they have not been investigated in the context of repeat instability or chromatin organization during aging and senescence. In this proposal we will investigate how Fob1 and analogous factors in human cells regulate rDNA stability and aging, potentially establishing a unexpectedly conserved paradigm.